Investigating Ultra-High-Quality Graphene-Based Cryo-EM Device Architecture for Higher Reproducibility, Speed, and Resolution

Project Summary
Cryogenic Electron Microscopy (Cryo-EM) has revolutionized macromolecule imaging by providing near-atomic
scale resolution insights into complex biological molecules' structures. However, current sample preparation
methods face challenges like denaturation, aggregation, and preferential alignment, limiting reproducibility and
efficiency. The limitations of imaging methods hinder scientific advancements which directly affect the ability to
develop novel vaccines and drug discovery. As AI-guided computational techniques emerge for mapping
protein structures, there is a need for imaging methods to evolve alongside. Graphene offers an ideal solution
for addressing these challenges. Sindri Materials has developed unique, ultra-high-quality (UHQ), large-area
graphene production that is reproducibly atomically clean and continuous. This graphene is critical for
observing unobscured atomic features and ensuring survivability during cryo-EM sample preparation.
Preliminary results strongly suggest that graphene growth quality is more intricately connected with high-quality
transfer than previously thought, necessitating a renewed investigation into transfer methodologies. The goal is
to develop a graphene-based cryo-EM device architecture that preserves key UHQ characteristics and enables
reliable, reproducible, and rapid cryo-EM integration. This will include investigating factors such as surface
adhesion, transfer-induced defects, and plasma treatment in transferring to produce a clean, continuous, and
strong graphene grid suitable for cryo-EM. Aim 1 examines the development of an optimized graphene transfer
method by examining support materials, quantifying transfer-induced residue, and assessing the mechanical
response of graphene. The aim is to maximize graphene integrity and minimize sample damage during the
process of transferring graphene onto a cryo-EM grid. Aim 2 examines the effect of varying degrees of plasma
treatment on the mechanical performance of graphene, an important factor in cryo-EM sample preparation.
The aim is to determine the extent of plasma exposure before significant mechanical property deterioration
occurs. This research aims to establish the methodology to fabricate UHQ graphene-based cryo-EM device
architecture necessary to address rampant image capture challenges faced by structural biologists, leading to
higher reproducibility, speed, and resolution, and therefore expanding the capabilities of researchers to
develop groundbreaking advancements in therapeutics and vaccines improving human health. The success of
this research will demonstrate the technical feasibility and define the parameters necessary for scaling up
commercial production to meet the growing market demand in a potential Phase II.

Public health relevance
Project Narrative Cryogenic electron microscopy (cryo-EM) plays a crucial role in public health by enabling detailed structural analysis of biological molecules, including viruses, proteins, and macromolecular complexes, which is essential for understanding disease mechanisms, developing targeted therapies, and designing vaccines to combat infectious diseases such as COVID-19. However, its full potential is hindered by the lack of an innovative, reliable, and scalable device architecture for position macromolecules, limiting imaging speed and resolution. Overcoming these limitations by leveraging ultra-high-quality graphene could unlock groundbreaking discoveries in public health by providing true atomic scale visualization and accelerating research and interventions.